Development and Validation of the Sibling Prosocial Relationship Questionnaire

PROJECT ABSTRACT
This research advances the measurement of sibling relationship quality by rigorously developing the Sibling
Prosocial Relationship Questionnaire (SPRQ), a child- and parent-report measure of sibling relationship quality
for children between the ages of 8 to 17, and establishing its reliability and validity. Sibling relationships, being
one of the longest-standing relationships across the life course, significantly influence human development and
behavior, serving as a critical foundation for later social development, including peer and romantic
relationships. Despite strong evidence linking social connection to child health and well-being, inadequate
measures hinder exploring the potential of sibling relationship quality. The validity of existing measures is
compromised due to serious limitations in their development such as narrow conceptualizations of family (i.e.,
primarily white, two-parent, middle-to-upper class), inadequate item development and refinement (i.e., minimal
use of content expert consultation), reductionist operationalization of relationship quality (i.e., dichotomy of
positive/negative or conflict/warmth), and limited analytic approaches (i.e., reliance on reliability estimates and
principal components analyses rather than factor analysis and item response theory [IRT]). An innovative
conceptual work by Kramer provides a framework to expand upon and update existing measures of sibling
relationship quality by shifting the focus from occurrences of behaviors (conflict/warmth) to social processes
that promote prosocial forms of sibling interactions within the context of the family system. For example, how
sibling conflict is resolved, rather than the occurrence or absence of conflict itself, is instrumental for the
development of child social, emotional, and cognitive competencies. This study addresses the limitations of
existing measures by using the rigorous and contemporary PROMIS® methodology for the first time in sibling
relationship research, which will enhance measurement precision and reliability. The specific aims are: Aim 1:
Develop the SPRQ, an English and Spanish child- and caregiver-report measure of sibling relationship quality,
through thematic analysis, expert interviews, and cognitive testing. Aim 2: Establish the measurement
properties of the SPRQ using factor analysis, item response theory, and differential item functioning
assessments. Aim 3: Determine associations between the SPRQ and child outcomes, validating it against
measures of behavioral and emotional attributes, and examine the direction and magnitude of association of
the SPRQ with emotional and behavioral regulation, and other social relationships.This innovative approach
has the potential to transform research and clinical practice by providing robust, actionable insights into the
mechanisms and trajectories of sibling relationships, thus identifying malleable components that can be
targeted in interventions. By capturing prosocial forms of sibling interactions, the SPRQ can lead to more
effective strategies for enhancing social connections and improving child and adolescent health and well-being.

Public health relevance
PROJECT NARRATIVE Siblings have major influences on human development and behavior, and learn from each other during everyday moments of play and family activities, which provide opportunities for them to acquire important social, emotional, and behavioral skills. Before we can understand the processes by which sibling relationships quality lead to positive or negative impacts on child and adolescent health, we need a structurally valid and psychometrically sound measure developed for sibling relationships, particularly among diverse socio-economic populations. The quality of this tool is potentially transformative for research, and fills a crucial gap by expanding the study of sibling relationships to include prosocial forms of sibling interactions, potentially leading to substantial clinical utility by identifying malleable components of sibling relationships that enhance child and adolescent health.